SYSTEMS APPROACHES TO THE EPIDEMIOLOGY, GENETICS AND GENOMICS OF LUNG DISEASES

ABSTRACT
Channing Division of Network Medicine Training Program in Systems Approaches to the Epidemiology,
Genetics, and Genomics of Lung Diseases
This training program is a competing continuation of a program funded by Institutional Ruth L. Kirschstein
National Research Service Award T32 HL007427. The program, which has operated continuously for the past 46
years, focuses on chronic respiratory diseases that are major public health problems--asthma and chronic
obstructive pulmonary disease (COPD). Based on our current limited understanding of these complex lung
diseases, there is a critical need for individuals trained in the application of systems approaches to epidemiology,
genetics, and genomics to perform quantitative research in respiratory biology. This T32 program is instrumental
in meeting this need, successfully training independent research investigators who go on to lead their own
research programs across the U.S. and Canada. The program provides research training in seven areas:
systems genetics; systems biology and network modeling; transcriptomics; functional genetics; other Omics;
epigenomics; and bioinformatics/data science. Six postdoctoral and two predoctoral training positions are
requested in this proposal, with a typical appointment duration of three years. The trainees interact with a pool of
36 faculty members in the seven interrelated research areas. Each trainee will have the opportunity to become
involved in the design, execution, and analysis of ongoing federally funded research projects as well as develop
an independent career path. Trainees’ research is conducted at the Channing Division of Network Medicine, a
research division of the Department of Medicine at Brigham and Women's Hospital (BWH) and Harvard Medical
School (HMS). Predoctoral trainees work toward a Ph.D. in network science, biostatistics, or epidemiology.
Postdoctoral trainees undertake didactic classroom work leading to a Master of Science (M.S.) in epidemiology
or a Master of Public Health (M.P.H.) degree at the Harvard T.H. Chan School of Public Health (HSPH) or a
Master of Medical Science (M.M.Sc.) degree in bioinformatics at HMS. After completing our program, trainees
will be eligible to assume faculty positions in systems biology/biostatistics or genetics/genomics. Trainees benefit
from a close relationship with the HSPH Department of Biostatistics and the BWH Division of Pulmonary and
Critical Care Medicine. More than 85% of our postdoctoral trainee graduates in the past 12 years are active in
research, and 68% of them have obtained an NIH K-series grant or similar mentored award.

Public health relevance
PROJECT NARRATIVE Channing Division of Network Medicine Training Program in Systems Approaches to the Epidemiology, Genetics, and Genomics of Lung Diseases Providing appropriate training in the application of the latest quantitative data analysis methods to understand the pathobiological causes of major lung diseases will be essential for the next generation of leaders in respiratory population-based research. This T32 program will build on a successful track-record of training with both formal didactic education and mentored research experiences. The medical researchers trained in this program have made, and will continue to make, important contributions to our understanding of asthma and COPD that will ultimately lead to more effective treatment for these diseases.